Examination of sex hormone alteration on post-operative pain development and treatment

PROJECT SUMMARY/ABSTRACT
Chronic postoperative pain affects a small but significant surgery population. The goal of this project is to
preclinically translate and determine the overall contribution of altered sex hormone levels in vulnerable patient
populations. These studies will generate novel preclinical sex hormone-altered pharmacological models. This
project may identify new insights into those susceptible to developing chronic postoperative pain as well as a
greater understanding into underlying genetic and genomic mechanisms.
Although many individuals with underlying altered sex hormone levels undergo surgical procedures,
most preclinical studies do not attempt to address this highly relevant patient population. As it is well
documented that sex hormones play pivotal roles in pain development and maintenance, this is striking. In
particular, the role of basally altered sex hormones in gonad-intact preclinical post-surgical pain models is
relatively unknown and understudied. Furthermore, the genome-wide and tissue-specific genetic changes that
sex hormone alterations may produce before, during, and after surgery have yet to be elucidated. Precise
manipulation of hormone levels to establish chronic post-surgical pain causation is not possible in humans. To
identify targets for improved post-surgical recovery we will therefore take advantage of a clinically informed sex
hormone altered rodent models as well as validated behavioral endpoints. Our central hypothesis is that within
vulnerable patient populations, sex hormone alterations occur, contribute to changes in mood, and both sex
hormone alterations and mood changes predispose those vulnerable individuals towards post-surgical chronic
pain. To pursue this fundamental work, we will use a combination of molecular and whole organism
approaches in which I have significant expertise including mouse models of incisional surgery, pain-evoked
and pain-depressed behavioral readouts, as well as examination of fold-changes related to both the genome
and specific tissues. This convergence of capabilities uniquely positions my independent laboratory to answer
key knowledge gaps: 1) Sex hormones are critical in the development and maintenance of chronic pain, but
can pharmacological modulation be monitored in vivo via pharmacokinetic measures to identify correlative
pain-related behaviors? 2) What specific genetic alterations occur due to sex hormone alterations? 3) Are the
sex hormone alterations seen within the surgical patient population relevant to the use and potency of post-
surgical analgesics? Ultimately, these studies will establish how sex hormone alterations may influence post-
surgical pain recovery. Successful completion of the proposed studies may enhance our understanding of sex
hormone alterations within vulnerable patient populations, and the role of sex hormones on healing after
surgery, identify associated -omics related changes, and clarify analgesic treatment options.

Public health relevance
PROJECT NARRATIVE Post-surgical pain is common amongst those recovering from a surgical procedure. However, a small but significant surgical population experience chronic post-surgical pain. Although it is generally understood that sex hormones contribute to the development and maintenance of pain, including chronic pain, little is known about the role that basal sex hormone alterations play in development and maintenance of chronic post- surgical pain or analgesic post-surgical pain management. The work proposed herein seeks to develop novel altered sex hormone models that mirror the surgical patient population, as well as elucidate antinociceptive profiles.